LONG TERM EVALUATION OF MAXILLARY SINUS BONE GRAFTS WITH DENTAL IMPLANT

This is a long-term follow-up of an earlier study, "Restoration of Oral Function with Maxillary Bone Grafts and Implants." The purpose is to learn whether there have been bone changes around the implants; this will be done by CT scan and dental x-rays. Participants will be followed for three years.